Systems-level identification of key regulators deciding immune cell state

Abstract
Understanding the mechanisms and identifying regulators of immune cell development and
differentiation are critical for developing new and more effective therapeutics. The fast
advancement of genomic technologies provides an unprecedented opportunity to study the
immune cells at the system level. The noise in the high throughput measurements and the
complexity of multiple omics data make it an urgent need for developing novel and powerful
systems biology approach for integrative analysis to reveal the underlying regulatory
mechanisms for immune system. We propose a new method to integrate multiomics data at the
genetic network level for identification of key regulators deciding the cell state and cell fate
(Specific Aim 1). We will apply the method to systematically uncover the regulatory mechanisms
in the mouse immune system by analyzing 86 immune cell populations (Specific Aim 2). We will
also perform comparative analysis of the human and mouse immune cells to reveal the
conserved regulatory code for immune cell specification (Specific Aim 3). We will rigorously
assess the performance of the computational analysis, experimentally confirm the importance of
the identified key regulators and investigate their roles in regulating immune cell functions. Once
complete, the proposed work will provide not only a general tool for integrative analysis of
multiomics data but also specific mechanistic insights for understanding the regulation of
immune system functions.

Public health relevance
Narrative The immune cells are diverse and have different functions despite they all share the same genome. Deciphering the regulatory program defining the cell types and cell state is thus important for developing new therapeutics.